TASK A108: COTTON RAT MODEL FOR THE EVALUATION OF RSV VACCINES AND THERAPEUTICS

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.